VR-CARES: Feasibility of Virtual Reality for Caregiver Assembly, Relief, Empowerment, and Support to improve social connection, health, and at-home dementia care

The escalating demand for home-based caregiving, combined with a high turnover rate and prevalence of stress
and burden in this workforce, presents a unique challenge within the healthcare sector. High turnover rates are
especially difficult for care recipients with dementia who benefit from consistency. Caregivers are often socially
isolated at work due to the intimate care they provide to socially isolated clients. The VR-CARES initiative is an
innovative response to these issues built upon Rendever's existing social engagement VR platform and vast
content to provide a novel caregiver support virtual reality (VR) platform for dementia caregivers providing in-
home care that generates real community and connectivity. Rendever, a pioneer in VR for older adults enables
shared experiences with networked communication technology so that wherever someone is geographically,
they can connect with others for group travel, activities, games, and sharing life stories. Caregivers can use
Rendever with clients to make their job more fun and get to know their clients better, resulting in fewer
negative behaviors of care seekers, improved relations and trust, and higher job satisfaction. Additionally, the
project will harness the power of VR to create virtual support groups in which caregivers can connect virtually
as avatars in comforting and immersive environments for friendship building, debriefing about their day,
receiving training, attending NAMI-led support groups, and just casually meeting up. This project represents a
confluence of intentional technology and empathetic foresight, whereby dementia caregivers are not merely the
subjects of a technological intervention but active participants in its development. In this STTR Phase I
study, we co-develop and test the feasibility and technological merit of a new VR platform
tailored to the nuances of caregiving – a gathering place for caregivers that resonates with the
experiences and needs of home health workers and prioritizes their social and mental health by
providing them with a safe, accessible, space for social support and fun, shared experiences.
The guiding vision is to transform the isolating landscape of home healthcare into one of communal support
and enrichment for both the caregiver and the person living with dementia in their care. Phase 1 aims to (1)
draw upon the lived experiences of caregivers, inviting them to inform the development of the VR environment,
(2) develop the content, features, and controls informed by aim 1, and (3) use outcome data on social and
mental health, caregiver burden, and job satisfaction to plan a clinical trial for Phase II. The expected outcome
is a user-centric, successfully adopted VR support system that alleviates feelings of loneliness and stress and
cultivates resilience and job satisfaction among caregivers. By embracing a collaborative model where the end-
user is central to the creative process, VR-CARES ensures that the Caregiver VR platform is intrinsically
aligned with the caregivers' reality, facilitating genuine connection and empowerment, and signaling a pivotal
shift towards technology that serves and is shaped by those at the heart of dementia care.

Public health relevance
The VR-CARES project is an innovative, collaborative effort that invites home health dementia caregivers into the design process of a virtual reality platform seeking to mitigate their work-related burden and social isolation by cultivating a virtual community of support. The co-created, caregiver-specific VR platform will serve as a safe, communal space where caregivers can remotely connect with their peers, share fun experiences together, access support, learn self-care and build resilience within a supportive virtual network to enhance their social and mental health and job satisfaction. Central to VR-CARES is the principle of user-led innovation, ensuring that the technology not only serves but is informed and successfully adopted by the very individuals it intends to benefit, an important standard for empathetic and inclusive technology in healthcare.